Prospective Studies Of Phlebotomy Therapy In Hereditary Hemochromatosis

Persons with hemochromatosis were recruited via Internet-based educational and referral information and by letters to area physicians. Comprehensive care and phlebotomy therapy were offered free of charge regardless of whether subjects met criteria for allogeneic donation. Hemoglobin of 12.5 g/dL(for females) 13.0 g/dl (for males), the regulatory thresholds for blood donation in the U.S., were used as the thresholds for performing phlebotomy, and decreases in the mean corpuscular volume (MCV) and ferritin were used to guide the endpoints of therapy. 582 subjects with iron overload were enrolled as of August 31, 2019. 68% of subjects were homozygous for the C282Y mutation in the HFE gene, 68.4% met eligibility criteria for allogeneic donation, and 57% were previous blood donors. A median of 25 weekly or biweekly phlebotomies (range 7-99) were performed before the ferritin reached the targeted endpoint of 50-150 mcg/L. The median phlebotomy interval necessary to keep the ferritin at this level during maintenance therapy was 20 weeks. Hemochromatosis donations were safe: no incident seroconversions for agents of transfusion-transmissible disease occurred during 10,810 donations made by HH donors from 2002 through 2019. As of August 31, 2019. Hemochromatosis donors were contributing 378 units of red cells since last annual report, resulting in a contribution of 7.8% of the units collected for allogeneic use in the NIH Clinical Center, and 185 units distributed for research use to NIH investigators from HH donors who did not meet standard allogeneic eligibility criteria. Family member screening and counseling were facilitated by concentrating the care within the Blood Center. Our data demonstrate that hemochromatosis subjects can safely and significantly augment the allogeneic blood supply. Provision of phlebotomy therapy in the Blood Center, unrestricted by considerations of insurance reimbursement or suitability for donation, can improve access to care and remove incentives for incomplete risk disclosure. Evaluations performed to date in this cohort indicate that there is a higher than expected incidence of thyroid abnormalities in hemochromatosis subjects, most commonly subclinical hypothyroidism. Thyroid function abnormalities were found in 24.1% of female subjects with homozygosity for the C282Y HFE mutation. A series of cardiology studies in these patients indicated that C282Y homozygotes have a statistically increased incidence of mild, subclinical abnormalities in atrial contractility and exercise-associated arrhythmias when compared to normal subjects, and these changes may be associated with elevated serum markers of oxidative stress. Left ventricular contractility and response to stress were found to be normal in C282Y homozygotes compared with control subjects. A comprehensive analysis of arthritis in these subjects revealed that 12.2% (48/394) C282Y-homozygous versus 3.7% (7/188) non-homozygous subjects underwent a total of 51 total hip, 30 total knee, and 11 total ankle replacements. The frequency of total joint replacement was significantly greater in C282Y-homozygotes than in the control group. The cumulative risk of total joint replacement hemochromatosis subjects was 31%. Among C282Y homozygotes, the risk of total joint replacement was markedly greater in subjects with initial ferritin levels greater than the median value of 735 mcg/L. Among the estimated 23,966 Caucasian U.S. males age 40-79 undergoing total hip replacement each year, the data suggest that 3-4% are C282Y-homozygous.